11/11 Connectome-based fingerprinting of alcohol drinking in mice: mechanisms and biomarkers

SUMMARY
In the current INIA period, we have developed multimodal brain MRI in mice, i.e. combining morphological,
structural and functional data. Our data demonstrate circuitry-specific alterations of brain morphology, and
reshaping of both structural and functional connectomes after 6 weeks excessive alcohol drinking. Our findings
are consistent with the human literature and demonstrate our ability to characterize in-depth whole brain plasticity
in a mouse model of alcohol drinking. We will build on these findings and methodologies to achieve three goals:
Specific Aim 1. Longitudinal MRI biomarkers - Group level analysis: do alcohol effects on
neurocircuitry depend on drinking history, and/or sex? We will continue to use the EOD-2BC model and
C57BL/6 mice and incorporate female mice in longitudinal Experiment 1. We will acquire multimodal MRI images
at four time points (baseline; 6 and 10 weeks drinking; 4 weeks withdrawal) and apply quantitative multiparametric
analyses to investigate temporal and sex effects. Brains will be collected for histology, c-Fos analysis,
metabolomics and transcriptomics (to be used in Aim 3).
Specific Aim 2. Connectome/behavior individual signatures – Subject level analysis: can we
classify and predict behavior and drug effects from MRI? We will move from group analysis to subject-level
analysis and correlate multimodal MRI data with individual behavioral patterns using machine learning
approaches. This is now feasible (GPR88 knockout mice/EOD-TBC,preliminary results). We will: Aim 2a. Identify
connectome features that classify and predict alcohol drinking/withdrawal behavior. We will build a predictive
multivariate model of the drinking trajectory at individual level, using longitudinal imaging data from Experiment
1. We will determine best MR-based connectome classifiers that discriminate drinking patterns and evaluate their
respective causal influence on the negative affect of withdrawal. Aim 2b. Identify connectome features that
predict drug treatment efficacy. We will study alcohol effects in male mice in longitudinal Experiment 2, which
will include a drug treatment. We have selected a GPR-88 agonist, which reduces alcohol intake. We will expand
the prediction model from Aim 2a to drug effects and include c-fos endpoints in the prediction (Kash/INIA-S).
Specific Aim 3. Mechanisms: can we link connectome data with neuroimmune signaling? This aim
will be synergistic with INIA partners, using notably molecular data from the same mice (see Aim 1). We will: Aim
3a. Develop hypothesis-driven analyses to identify MRI correlates for neuroadaptations in extracellular matrix
(Lasek), microglia (Mangieri) and stress centers (AI, BNST, Kash). Aim 3b. Perform metabolomic profiling using
HR-MAS (high resolution magic angle spinning) 1H-NMR at our site, for regions of interest based on our
collaborative work. We will compare metabolic profiles of immune pathways with those obtained from mice
undergoing the CIE-protocol (Kroenke-Cuzon/INIA-S). Aim 3c. Integrate transcriptomic brain mapping
(Mayfield) with our MRI data to correlate altered gene expression and brain network remodeling in the EOD-TBC
model.
In conclusion, Specific Aim 1 will strengthen validity of our MRI-based fingerprinting approach in mice,
address the yet poorly understood sex effect at whole brain level, and will be applicable to other mouse models
of AUD. Specific Aim 2 will establish signatures of alcohol effects and drug treatments, with potential for diagnostic
and patient stratification, confirm GPR88 as a target to treat AUD, and will be applicable to other INIA drugs.
Specific Aim 3 will bridge our “mesoscale” data with molecular and cellular mapping INIA projects.

Public health relevance
NARRATIVE In the past period, we established mouse MRI is a feasible approach to establish fingerprints for both structural and functional adaptations of the whole brain connectome to alcohol exposure. Here we will expand this methodology and develop new analytic methods to answer three questions: (i) do alcohol fingerprints differ along the drinking trajectory, and between sexes? (ii) can we classify and predict drinking behavior and drug effects for individual subjects from MRI? and (iii) can we bridge MRI data with molecular immune brain mapping (INIA synergy)?